PACAP/PAC1R signaling and CRH intersections in micturition circuits: effects of stress and injury/inflammation

Project Summary/Abstract
Bladder Pain Syndrome (BPS)/ Interstitial Cystitis (IC) is a chronic pelvic pain disorder characterized by suprapubic, pelvic
pain with at least one urinary symptom. Stress exacerbates symptoms of BPS/IC. Despite intense research, we lack
understanding of how structural and functional changes in the micturition reflex are linked to BPS/IC and how stress
exacerbates symptoms, thus impeding effective therapies. Expanding upon our previous collaborations, integrating our
diverse scientific disciplines, and combining our unique laboratory strengths, we will use a repeated variate stress (RVS)
overall hypothesis that increases in urinary frequency
and pelvic pain from stress- and inflammation/injury-induced changes in central micturition and peripheral sensory circuits
reflect pituitary adenylate cyclase activating polypeptide (PACAP)/PAC1 receptor mediated signaling and corticotropin
releasing hormone (CRH) interactions to engender a pro-excitatory state
and cyclophosphamide (CYP) injury/inflammation models to test the
. Building from our previous work, we will assess
how maladaptive intersections between the CRH and PACAP/PAC1R central micturition neurocircuits and peripheral lower
urinary tract (LUT) pathways may be contributory to stress-induced urinary bladder dysfunction and pelvic pain.
Aim 1:
To test whether RVS induces changes in CRH and PACAP/PAC1R expression and neuroplasticity in the pontine
micturition complex (PMC; Barrington’s nucleus).
Hypothesis: Our previous studies have demonstrated
PACAP/PAC1R phenotypic plasticity after stress challenges. In concert, we anticipate that RVS will similarly result in
central micturition pathway PACAP/PAC1R and CRH plasticity to alter voiding and pain responses.
Aim 2: To test
whether modulating PMC PACAPergic system and downstream CRH signaling alters voiding frequency and/or
pelvic pain.
Hypothesis: Regulation of PACAPergic signaling and CRH interactions in the PMC will modulate micturition
and somatic sensitivity responses in normal and stressed states.
Aim 3: To test whether modulating PACAP/PAC1R
signaling and CRH pathways in the sensory components of the micturition reflex alters CYP- and RVS-induced
voiding frequency and pelvic pain sensitivity.
Hypothesis: We have shown previously that CYP-induced cystitis increases
PACAP expression and signaling in sensory neurons. Accordingly, we hypothesize that blocking enhanced PACAP/PAC1
signaling from stress and injury/inflammation-induced plasticity in mice decreases voiding frequency and pelvic pain in
part by modulating urothelium function. These studies are significant in advancing: (1) mechanistic insights to the
underlying structural and functional changes contributory to stress- and injury/inflammation-induced changes in voiding
behavior and pelvic pain; (2) the effects of psychological stress on central circuits underlying bladder function and pelvic
sensation and (3) identification PACAP/PAC1R-mediated signaling and interactions with CRH/urocortin pathways as novel
targets for stress- and injury/inflammation-induced urinary bladder dysfunction and pelvic pain.

Public health relevance
Project Narrative We lack understanding of how structural and functional changes in the micturition reflex are linked to bladder pain syndrome/interstitial cystitis and how stress exacerbates symptoms, thus impeding effective therapies. We hypothesize that increases in urinary frequency and pelvic pain from stress- and inflammation/injury-induced changes in central and peripheral micturition circuits reflect pituitary adenylate cyclase activating polypeptide (PACAP)/PAC1 receptor-mediated signaling and corticotropin releasing hormone (CRH) interactions to engender a pro-excitatory state. We will assess how maladaptive intersections between the PACAP/PAC1R pathways and CRH may be contributory to stress-induced urinary bladder dysfunction and pelvic pain.